The Community Paramedic Response and Overdose Outreach with Supportive Medical-Legal Services (CROSSROADS) Study

ABSTRACT
Overdose continues to be a leading cause of death in the US with certain social and structural vulnerabilities
increasing risk. People who are exposed to or impacted by the criminal legal system (CLS) disproportionately
report using substances and experience high rates of overdose. In recent years, deep investment in assuaging
the impact of the CLS on overdose risk has been made. However, less work has been done to uncover how
best to deploy and optimize community interventions at earlier points of the sequential intercept model (e.g.,
preventing arrest and incarceration) to prevent adverse substance use and CLS outcomes for those at greatest
risk. Community paramedic (CP) programs have launched nationally in response to the overdose epidemic in
large part due to the acknowledgement that non-punitive interventions are effective. While different models
exist, a main component of CP programs is the deployment of non-armed first responders via 911 after an
overdose call, a de-facto alternative to police. CPs provide life-saving intervention (e.g., naloxone), MOUD,
linkage to community-based health and social services, and follow-up after the initial interaction. Early results
of these programs show promise as a non-carceral oriented substance use intervention that also reduces
further CLS penetration. CPs outreach is not limited to one-time encounters, and the longevity of contact with
people who overdose is important to establish trust, “meet people where they’re at” and provides consistent
post-overdose follow-up after the initial interaction. However, CP programs intervene primarily on the individual
level and, increasingly, research indicates that, for optimal impact, structural-level factors must be considered.
Particularly relevant to CLS populations is the need to address health harming legal needs (HHLN) including
lack of access to public benefits, housing issues, and other unmet legal needs. Medical Legal Partnerships
(MLP) are a collaboration between legal and healthcare professionals that attempt to bridge structural, social,
and individual needs, and in this context, specifically those that increase the likelihood of further adverse
substance use harms. To our knowledge, few CP programs incorporate services traditionally offered via
MLPs. Therefore, we propose the Community Paramedic Response and Overdose Outreach with
Supportive Medical-Legal Services (CROSSROADS) Study. CROSSROADS will take place in Durham, NC;
Pittsburgh, PA; Miami, FL; and Portland, ME. Our aims are to: 1) Determine the core components of the
proposed CROSSROADS intervention (CP program + MLP); 2) Compare the CROSSROADS
intervention versus standard of care (SOC) CP programs across the four locations on 1) frequency opioid
and/or stimulant use, and 2) CLS (police, incarceration, and probation/parole involvement); and 3) Identify the
acceptability, appropriateness, penetration, and sustainability of the CROSSROADS intervention and
multilevel factors that affect overdose and future interactions with the CLS.

Public health relevance
NARRATIVE Involvement in the Criminal Legal System (CLS) can create and exacerbate adverse substance use outcomes, including overdose, and recidivism. While much investment has been made in and with carceral systems to mitigate this risk, less has been focused on non-punitive community programs that can impact substance use and future CLS contact. Therefore, we propose conducting a hybrid type 1 study to develop, test, and optimize a community paramedic + medical legal partnership intervention in Durham, NC, Pittsburgh, PA, Portland, ME, and Miami, FL.